Functional analysis of autism risk genes during neural development using single cell seq

The brain represents a complex organ with a myriad of functionally diverse
cell types. Autism spectrum disorder (ASD) is thought to alter the combinatorial
transcriptional and post-transcriptional code responsible for specifying and
maintaining different cell functions in the vertebrate brain. The proposed studies
will test the central hypothesis that chromatin/transcriptional regulators identified
as ASD risk genes act as developmental switches during early
neurodevelopment, altering the gene expression network and subsequent cell
function.
In this proposal we combine single cell sequencing, with genetic, genomic
and computational approaches in zebrafish and embryoid bodies to i)
characterize the role of ASD-risk genes in healthy neural gene regulatory
networks (Aim 1); 2) Interrogate the effects of ASD loss-of-function (LOF)
mutations in different neural lineages (Aim 2). Cell types and developmental
lineages within the brain that are more significantly affected by each candidate
ASD risk gene will be identified using zebrafish and human cell–derived
organoids.
The experiments outlined in this proposal have the ultimate goal of
identifying how ADS risk genes affect neural gene expression and cell function
during vertebrate development.

Public health relevance
Autism is a neurodevelopment disorder, yet the cell types that are affected by different mutations identified in human are poorly understood. In this proposal we will investigate how mutation in ASD risk genes affect the expression of different genes across the different neuronal cells during development using cell culture and vertebrate embryos in zebrafish. The results derived from this proposal are likely to provide key insights into the basic mechanism of shaping gene expression in the normal brain and in ASD affected brains.